Actions of spiropyrimidinetriones against bacterial type II topoisomerases

PROJECT SUMMARY
Antibacterial resistant infections cause more than 1.2 million deaths around the world each year, and this
number is predicted to grow to 10 million by 2050 unless resistance is effectively curbed. A pathogen of particular
concern is drug-resistant Neisseria gonorrhoeae, which is listed as one of five “urgent threats” (the highest threat
level) by the Centers for Disease Control and Prevention (CDC). Fluoroquinolones (FQs) were recommended
as frontline treatment for the 98 million annual cases of gonorrhea since 1993, but their use was discontinued in
2007 due to increasing levels of target-mediated resistance. This resistance occurs when specific mutations in
the target for FQs, the bacterial type II topoisomerases, gyrase and topoisomerase IV, arise in response to FQ
treatment. One strategy to overcome resistance is to develop new compounds that interact with bacterial type II
topoisomerases at amino acid residues distinct from those of FQs. Using this approach, a new class of
gyrase/topoisomerase IV-targeted agents with a spiropyrimidinetrione (SPT) pharmacophore was identified.
Gyrase and topoisomerase IV regulate the topological state of DNA in bacterial cells. These essential
enzymes control levels of DNA supercoiling (over- and underwinding) and remove knots and tangles from the
genetic material by passing an intact double helix through a transient double-stranded DNA break generated in
a separate DNA segment. Both FQs and SPTs stabilize the covalent enzyme-cleaved DNA complex (cleavage
complex) such that when advancing replication and transcription machinery approach these complexes, they
can fragment the genome, triggering the SOS response and other cell death processes. The primary goal of this
project is to overcome FQ resistance in N. gonorrhoeae by increasing our understanding of SPT interactions
with gyrase and topoisomerase IV and target-mediated resistance development across bacterial species to
inform the design of more potent and efficacious antibacterials. This goal will be addressed by three specific aims:
In Specific Aim 1, I will assess the actions of SPTs against gyrase and topoisomerase IV from N.
gonorrhoeae, Bacillus anthracis, and Escherichia coli to determine how the activities of this class varies across
bacterial species. To this end, I will use assays that measure DNA cleavage, cleavage complex stability, and
catalytic inhibition with wild-type enzymes. In Specific Aim 2, I will evaluate the ability of novel SPTs to overcome
FQ- and SPT-resistance mutations in gyrase and topoisomerase IV and describe the basis by which mutations
in these enzymes confer resistance to SPTs. This will require similar enzymological activity assays as described
in Specific Aim 1. In addition, I will measure SPT-enzyme binding interactions and conduct competition studies
to determine if resistance mutations affect drug binding and/or placement in the gyrase/topoisomerase IV active
site. Finally, in Specific Aim 3, I will assess the levels and persistence of SPT-stabilized cleavage complexes
generated by gyrase and topoisomerase IV in N. gonorrhoeae cells using an in vivo complex of enzyme bioassay.
These studies have the potential to inform the development of new drugs to overcome antibacterial resistance.

Public health relevance
PROJECT NARRATIVE Increasing rates of antibacterial resistance in Neisseria gonorrhoeae and other species require more effective methods for treating bacterial infections. The bacterial type II topoisomerases are targeted by one established and two emerging classes of antibacterial compounds: fluoroquinolones, novel bacterial topoisomerase inhibitors, and spiropyrimidinetriones. Using biochemical and enzymological assays and tools such as site- directed mutagenesis, fluorescence anisotropy, and the in vivo complex of enzyme bioassay, my project will define the interactions of spiropyrimidinetriones with gyrase and topoisomerase IV from N. gonorrhoeae, Bacillus anthracis, and Escherichia coli with the goal of informing the development of new antibacterials that overcome target-mediated fluoroquinolone resistance.